Sex differences in the genetic etiology of cognitive resilience to Alzheimer's disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is a progressive, neurodegenerative disorder marked by hallmark pathologies,
amyloid plaques, and neurofibrillary tangles, leading to downstream consequences including
neurodegeneration and cognitive impairment. However, 30% of elderly adults are cognitively resilient to AD,
presenting with AD pathology yet never presenting with downstream consequences. Applying the cognitive
resilience framework to genetic studies has resulted in the identification of novel genetic loci that differ from
known AD genetic loci. However, to date, the cognitive resilience framework has yet to be explored in a sex-
specific manner. Sex differences in AD pathogenesis are well-established, with growing evidence suggesting
genetic factors may contribute to these differences. Thus, this F31 proposal will investigate sex differences in
the genetic etiology of cognitive resilience to AD. We will leverage cognitive, biomarker, and genetic data from
eleven well-characterized cohorts of cognitive aging. To build robust cognitive resilience phenotypes, we will
implement latent variable modeling, and then perform a series of sex-aware genomic analyses on the resulting
phenotypes. First, we will perform sex-stratified and sex-interaction genome-wide association studies (GWAS),
followed by gene-level tests, including applying sex-specific predicted gene expression models. Second, we
will perform X-wide association studies (XWAS). To date, there have been no XWAS on AD cognitive
phenotypes, due to the X-chromosome’s additional challenges arising from dosage differences between sexes.
To this end, we will apply genetic pipelines tailored for the X-chromosome to allow for its inclusion. Third, we
will perform genetic correlation tests with the aforementioned GWAS and XWAS and a unique resource of
thousands of sex-stratified GWAS summary statistics on health-related traits from the UK Biobank. These tests
will identify shared genetic architecture between cognitive resilience and other complex traits, pointing to
possible sex-specific biological pathways driving cognitive resilience. Overall, the proposed research aims will
identify novel genetic loci, candidate genes, and molecular pathways associated with cognitive resilience to AD
pathogenesis in a sex-specific manner. To complete all aims, this F31 proposal will leverage cutting-edge
resources and the collaborative environment of the Vanderbilt Memory & Alzheimer’s Center. The candidate,
Jaclyn Eissman, will independently complete all statistical analyses with guidance from an expert mentorship
team. This team has expertise in computational genomics, clinical and biomarker contributions to AD, and sex-
aware genetic models of complex traits. The outlined research aims along with the detailed and parallel
training plan will allow the candidate to have the skills to successfully complete the proposed research aims
and enhance her professional development skills in preparation for a career in science. Findings from this F31
proposal will contribute to revealing novel insight into AD progression and to identifying novel therapeutic
targets that best suit an individual based on their genetic context and biological sex.

Public health relevance
PROJECT NARRATIVE Approximately 30% of elderly adults are cognitively resilient to Alzheimer’s disease (AD) pathogenesis, never presenting with downstream consequences of AD pathology, including neurodegeneration or cognitive impairment. Additionally, sex differences in AD pathogenesis are established, with growing evidence indicating genetic factors may contribute to these differences. To this end, this F31 proposal will take a precision medicine approach to investigate sex differences in the genetic etiology of cognitive resilience to AD, providing new insight into AD progression and contributing to the identification of novel therapeutic targets to treat AD.